Leveraging SNAP Policies to Improve Cardiovascular Health in the United States

A growing body of evidence suggests that food insecurity is associated with higher rates of cardiovascular disease and mortality. More than 34 million people experience food insecurity in the US, and 1 in 7 households are food insecure. Therefore, efforts to improve food insecurity may be important to improving cardiovascular health. During 2020, food insecurity increased dramatically among US adults, and in response the federal government took unprecedented steps to expand benefits through the Supplemental Nutrition Assistance Program (SNAP). These policy actions provided emergency allotments that collectively doubled the average SNAP benefit – the largest-ever increase. However, SNAP emergency allotments were recently de-implemented across 32 US states on March 2023, with some states electing to do so much earlier (2021), resulting in a significant increase in food insecurity. Many policy experts believe that this reduced investment in SNAP benefits could not only impede families’ ability to purchase healthy foods, but may also create competing financial demands that have adverse spillover effects. For example, families may need to choose between spending limited financial resources on food instead of important health care services and may also find it more challenging to afford (and adhere to) important medications, which could collectively worsen cardiovascular health.
However, these hypotheses have not been rigorously tested to date. The time-staggered way in which SNAP emergency allotments were de-implemented across US states provides a rare and unique opportunity to estimate the causal effects of changes in SNAP benefits, and to elucidate the pathways by which food insecurity impacts cardiometabolic health. In this proposal, will use a unique combination of national datasets, including survey data from NHIS, biometric & laboratory data from NHANES, and administrative claims data to accomplish three aims. In Aim 1 we will determine changes in food insecurity, including among adults with diet-sensitive cardiometabolic risk factors, from 2019 to 2024. In Aim 2, we will leverage the natural experiment created by some US states ending SNAP emergency allotment policies much earlier than others to evaluate their impact on health care access and affordability, the prevalence, treatment, and control of cardiometabolic risk factors, and self-reported health. In Aim 3, we will determine whether the de-implementation of SNAP emergency allotment policies led to changes in the incidence of acute cardiovascular events (myocardial infarction, heart failure, stroke), as well as associated outcomes. This research will advance our understanding of changes in food insecurity among millions of US adults, elucidate pathways by which food insecurity impacts cardiovascular health, and provide critical evidence on the spillover and health effects of SNAP. Our work could have important public health implications and inform strategies to address food security and improve cardiovascular health nationwide.

Public health relevance
Food insecurity increased sharply due to economic loss and unemployment in 2020, and in response, the federal government took unprecedented steps to increase nutrition benefits (emergency allotments) for millions of Americans through the Supplemental Nutrition Assistance Program (SNAP). A growing body of evidence suggests that food insecurity is associated with cardiovascular health, and so in this proposal, we will: (1) examine national changes in food insecurity, including among those with cardiometabolic risk factors, from 2019 to 2024; (2) elucidate the pathways by which food insecurity impacts cardiometabolic health; and (3) estimate the spillover and health effects of SNAP. To do so, we will leverage a natural experiment that occurred when US states de-implemented SNAP emergency allotments to estimate their impact on health care access and affordability, the prevalence, treatment, and control of cardiometabolic risk factors, and the incidence of acute cardiovascular events.